Partnership for Prevention of HPV-Associated Cancers in People Living with HIV: Brazil, Mexico, and Puerto Rico - Supplemental Extension

OVERALL ABSTRACT
The Partnership Center, entitled Research on Oral and Cervical Cancer, HPV and HIV
in the Americas (ROCCHHA), brings together experienced research sites and world-
renowned HPV and HIV researchers to build on established collaborations to conduct
clinical trials on prevention of HPV-associated cancers among people living with HIV.
ROCCHHA continues to provide an invaluable opportunity for newer investigators from
Latin America/Caribbean (LAC) to participate in and learn from high quality research.
ROCCHHA will focus on two HPV-associated cancers that result in substantial morbidity
and mortality: HPV-associated oropharyngeal cancer (HPV-OPC) and cervical cancer.
These scientific goals are aligned with the goals of the US National Institutes of Health
for research priorities for people living with HIV/AIDS as well as in country and regional
goals to reduce cancer morbidity and mortality. At the end of this project, we hope to
make advances that will highly impact prevention of HPV-associated cancers in people
living with HIV and contribute to the global goal of cervical cancer elimination and
reduction of other HPV-associated cancers such as oropharyngeal cancer (OPC).

Public health relevance
PROJECT NARRATIVE The project partnership, Research on Oral and Cervical Cancer, HPV and HIV in the Americas (ROCCHHA) brings together experienced research sites and world-renowned HPV and HIV researchers to build on established collaborations to conduct clinical trials on prevention of HPV-associated cancers among people living with HIV. We provide an invaluable opportunity for newer investigators from Latin America/Caribbean (LAC) to participate in and learn from high-quality research. We are performing clinical trials that will help reduce the burden of two HPV-associated cancers in LAC: HPV-associated oropharyngeal cancer and cervical cancer.